Exhaled volatile organic compounds, phospho-tau and postoperative delirium

Postoperative delirium (POD) is common, especially in elderly patients. Patients with Alzheimer’s
disease (AD) or AD-related dementias (ADRD) have a higher risk of delirium. Patients with delirium
have a higher chance to develop AD and ADRD. It has been shown that AD-related biomarkers, such
as phospho-tau and neurofilament light, in the blood are associated with POD. However, these tests
take time and are expensive to perform. Harvesting blood carries a minor risk. Patients with AD and
POD have metabolic dysfunction. Studies have shown that there are differences in the volatile organic
compounds (VOCs) in the exhaled gases between AD patients and healthy controls. Whether this
situation exists between patients with POD and non-POD is not known. Evaluating exhaled VOCs is
no-invasive and can be done at bed site with our equipment. We hypothesize that patients with POD
have a unique pattern of exhaled VOCs and that this pattern is associated with AD-related biomarkers
in the blood. To address these hypotheses, we will recruit 150 patients with spine surgery who are 65
years or older. Their exhaled gases will be analyzed by using advanced portable gas
chromatography. Their blood will be used to analyze tau, phospho-tau, neurofilament light and
amyloid beta peptides. The POD incidence and severity will be assessed. The VOC and blood
biomarker results of patients with POD will be compared with those of patients without POD. The
predicting values of VOCs and AD-related biomarkers for POD will be determined. These studies will
for the first time determine whether a no-invasive and quick analysis of exhaled VOCs can be used to
predict POD. The identified VOCs that contribute to the different patterns between patients with and
without POD will indicate metabolic pathways that are dysfunctional. The analysis of the correlation
between exhaled VOCs and AD-related biomarkers in the blood may reveal possible relationship
between AD-like neuropathology and exhaled VOCs. Thus, this project may provide initial evidence
for the role of VOCs in POD and AD-related neuropathology.

Public health relevance
Postoperative delirium (POD) is common and has a complicated interaction with Alzheimer’s disease. We will test a non-invasive method that analyzes our exhaled gases after spine surgery, one of the most common surgeries, to determine whether it can be used to predict POD and whether the profile is related to Alzheimer’s disease changes in the brain. These studies may provide initial evidence for the role of exhaled chemicals in POD and Alzheimer’s disease brain changes.